Genetic Susceptibility to Developmental Benzo[a]pyrene Neurotoxicity

Project Summary. This is a renewal application of an initial award to explore genetic susceptibility to
benzo[a]pyrene (BaP)-induced developmental neurotoxicity. BaP is a model polycyclic aromatic hydrocarbon
found in traffic-related air pollution (TRAP), wildfire and cigarette smoke and grilled foods. Human studies have
linked prenatal and early life exposure to PAHs with adverse effects on cognition and behavior persisting from
early childhood to adolescence. Extensive animal studies have strongly implicated aryl hydrocarbon receptor
(AHR) agonists including PAHs in developmental neurotoxicity. Our initial studies used mice with genetic
differences in the AHR and two metabolic enzymes regulated by the AHR: CYP1A1 and CYP1A2. All three
genes of interest vary in the human population and have been linked to adverse effects following exposure to
TRAP. Data from our initial studies strongly supported our hypothesis that the AHR pathway plays a key role in
mediating BaP developmental neurotoxicity. Both Cyp1a1(-/-) and Cyp1a2(-/-) knockout mice had greater
impairments in tests of learning and memory compared with wild type mice exposed to the same dose of BaP
during gestation and lactation. Interestingly, we also found differences in behavior based on genotype alone in
the knockout lines. This novel finding suggests both genes have a normal role in brain development or function.
Both humans and mice have three members of the CYP1 family, so our future work will probe the significance
of CYP1B1 and further explore mechanisms of neurotoxicity in the Cyp1a1 and Cyp1a2 knockouts. Aim 1:
Determine the role of CYP1B1 in BaP neurotoxicity by comparing Cyp1b1(+/+) wild type and Cyp1b1(-/-)
knockout mice using validated tests of learning & memory, behavior, and motor function, quantification of
neurotransmitters and gene expression in brain regions governing those functions. Our initial studies uncovered
increased susceptibility to developmental BaP exposure in mice lacking CYP1A1 and CYP1A2. These studies
will allow us to complete the characterization of the entire CYP1 family in our mouse model. Aim 2: Identify
changes in the gut microbiome and downstream metabolites associated with neuroprotection v
neuroinflammation. During our initial studies, we were able to do an exploratory analysis of the gut microbiome
in BaP-treated and control Cyp1a1(+/+) wild type and Cyp1a1(-/-) knockout dams and pups. We found significant
differences in beta diversity in BaP-exposed knockouts. Using a targeted metabolomics approach, we also found
striking differences in the tryptophan-kynurenine pathway in BaP treated Cyp1a2(-/-) knockout mice. These data
and recent studies identifying links between AHR activation and dysregulation of the TRP-KYN pathway suggest
a potential mechanism of neurotoxicity. As an AREA-R15 application, this will strengthen the research
environment at Northern Kentucky University, a predominantly undergraduate institution in the Greater Cincinnati
area serving a large percentage of diverse and disadvantaged students and support an Early Stage Investigator
who can train these students in the use of bioinformatics techniques.

Public health relevance
Project Narrative. Traffic-related air pollution, wildfire smoke, cigarettes, and grilled food all contain a significant concentration of polycyclic aromatic hydrocarbons (PAHs). Exposure to PAHs during early brain development is associated with lower IQ and behavioral problems, and these chemicals are also associated with changes in the gut microbiome that can impair normal brain development and function. We will use mice with genetic differences to identify individuals at highest risk prenatal following early life PAH exposure with an over-arching goal of protecting the most vulnerable human populations.